Molecular Mechanisms of Y-Family Translesion Polymerase Activity in Bacillus subtilis

Cells must efficiently and accurately replicate their genetic material, yet this process is challenged by the
presence of unrepaired DNA damage on the template strand. In the DNA damage tolerance pathway translesion
synthesis (TLS), specialized translesion polymerases replicate damaged DNA, promoting cell survival under
stress. Most TLS polymerases are lower fidelity than replicative DNA polymerases, and thus their activity must
be tightly regulated under normal growth conditions to maintain genome stability. Conversely, stress-induced
mutagenesis by TLS polymerases can promote cell survival under certain conditions, such as by contributing to
the development of antibiotic resistance in bacteria. The gram-negative bacterium E. coli has served as a model
species for mechanistic studies of TLS polymerase regulation, but it is not known whether the same principles
apply in other bacterial species, including the model gram-positive bacterium B. subtilis, which has two Y-family
TLS polymerases, Pol Y1 and Pol Y2. By combining biochemical and microbiological experiments with
live-cell single-molecule imaging, we will provide a comprehensive picture of the spatial organization,
dynamics, and molecular coordination of the TLS polymerases Pol Y1 and Pol Y2 in B. subtilis. This study
will reveal new insights into how DNA replication fidelity is maintained during normal growth and will broaden our
understanding of TLS and DNA damage tolerance in bacterial species beyond E. coli.
Aim 1: Determine how TLS polymerases respond to replication perturbations in B. subtilis
In E. coli, TLS polymerases are excluded from the replication fork during normal cellular growth but selectively
enriched in response to replication perturbations. It is not known, however, whether B. subtilis Pol Y1 and Pol
Y2 are regulated in a similar manner. We will use live-cell single-molecule imaging to visualize fluorescently-
labeled Pol Y1 and Pol Y2 molecules during normal replication and upon DNA damage, allowing us to determine
if and how they respond to replication perturbations.
Aim 2: Elucidate the role of the DnaN clamp in coordinating Pol Y1 and Pol Y2 activity
The bacterial replication processivity factor, the DnaN sliding clamp, interacts with a wide range of proteins
involved in DNA replication and repair through a common binding site. Pol Y1 and Pol Y2 contain clamp-binding
motifs (CBMs), short peptide sequences that bind to DnaN. We will combine biochemical and microbiological
assays with live-cell single-molecule imaging to elucidate the role of DnaN in regulating TLS in B. subtilis.
Aim 3: Determine whether and how interactions with SSB play a role in TLS polymerase recruitment
Bacterial single-stranded DNA-binding proteins (SSBs) act as a conserved binding platform for DNA replication
and repair proteins. In E. coli, the TLS polymerase Pol IV is selectively enriched at stalled replication forks
through its interaction with SSB. We will determine whether SSB plays a similar role in TLS polymerase
regulation in B. subtilis by combining biochemical binding assays with live-cell single-molecule imaging.

Public health relevance
Project Narrative: Unrepaired DNA damage is a potent block to DNA replication, inhibiting cell growth and ultimately leading to cell death if the blockade is not resolved. The DNA damage tolerance pathway translesion synthesis (TLS) allows cells to bypass unrepaired DNA damage during replication, but TLS polymerases are generally error-prone and thus can introduce harmful genetic mutations if improperly regulated. This project uses single-molecule fluorescence microscopy to elucidate how the TLS polymerases Pol Y1 and Pol Y2 are regulated to ensure replication fidelity in the bacterium Bacillus subtilis.